Building and shaping the apical extracellular matrix

Project Summary
Apical extracellular matrices (aECMs) are glycoprotein and lipid-rich layers that coat exposed
surfaces of epithelia to protect them from pathogen infection and other environmental stresses.
aECMs also shape and maintain integrity of apical domains (particularly those of narrow tubes)
and can form elaborate body decorations. Understanding aECM biology is important because of
the widespread roles that these matrices play in animal development and physiology, as well as
in human health. Defects in aECMs contribute to medical conditions including deafness, lung
disease, kidney disease, and vascular disease. A major challenge in the field has been the
difficulty of visualizing these complex matrices, which are often damaged by histochemical
fixation and not easily recapitulated within in vitro culture systems. This has hampered studies
of how aECM components traffic to the apical domain, assemble at the proper time and place to
execute their functions, form layers and three-dimensional substructures, and respond to
genetic or environmental perturbations. Such questions can be addressed using a simpler
model system. C. elegans has aECMs containing collagens, zona pellucida (ZP) domain
proteins, proteoglycans, phospholipids, and other factors similar to those in mammalian ECMs,
and it permits easy visualization of endogenous fluorescently-tagged aECM components in live
animals, along with facile genetic manipulations. A better understanding of C. elegans aECM
can inform the biology of conserved matrix protein families and what could be going wrong in
human matrix-related diseases, while also informing design of methods to counter pathogenic
nematodes. Important and broadly relevant questions addressed in this work include: 1) What
controls aECM assembly at the proper time and place? 2) How are complex three-dimensional
aECM structures formed and shaped? 3) What controls aECM protein secretion and
endocytosis? 4) How does metabolism influence aECM? These questions will be addressed
through genetic mutant analyses combined with light microscopy, electron microscopy, RNA
expression profiling, and lipidomics experiments.

Public health relevance
Project Narrative The insides of narrow tubes, like those the lung and vascular system, are lined by a protective coating that helps shape the tubes and prevent their collapse, while also repelling pathogens. These studies utilize a simple model organism to investigate how such coatings are made. Understanding these mechanisms will help in the design of therapies to prevent or treat tube- related disease.